Navigating Pathways of Innate Immunity and Epigenetic Memory in Checkpoint Immunotherapy

My laboratory has been at the vanguard of the discovery of costimulatory molecules and checkpoint inhibitors
and their role in cancer. The field of cancer immunotherapy has mainly focused on the impact of immune
checkpoints (IC) and their blockade on the activation of tumor-associated T cells. Although antigen recognition
is important, it is only one component of the process required for efficient induction of adaptive immunity. Work
in our existing program revealed that the PD-1 receptor is expressed in hematopoietic stem and progenitor cells
(HSPC) and recruits canonical PD-1: SHP-2 inhibitory axis to the GM-CSFRc, suppressing the phosphorylation
of the transcription factors HOXA10 which regulates myeloid cell differentiation, and IRF8 which epigenetically
instructs the differentiation of monocytes and dendritic cells. In mice with myeloid-specific ablation of PD-1: SHP-
2 axis, tumor myeloid cells had a gene expression program of enhanced differentiation, activation, phagocytosis,
chemokine activity, IFN-I, IL-1 and IL-6, which are required for generation of TEFF and TMEM responses. Bone
marrow monocytes from these tumor bearing mice displayed enhanced expression of IFN-I, IL-1 and IL-6, and
activation of STING and NLRP3, and transferred protective anti-tumor immunity to naïve hosts. These findings
support the novel hypothesis that, in the context of cancer, engagement of the PD-1:SHP-2 axis during HSPC
differentiation imprints a program compromising key APC activities required to stimulate antigen-specific T cell
responses, whereas its abrogation unleashes such APC functions. Understanding and recapitulating this process
will be the goal of my future project. This knowledge might lead to the identification of new targets for
personalized immunotherapy and new strategies to overcome barriers of immunotherapy. To achieve these,
during the next seven years, I will focus on the following research directions to:
A. Determine the impact of ICs on emergency myelopoiesis in the context of cancer. Emergency myelopoiesis
and innate immunity are intimately linked. We will systematically investigate how cancer cues and immune
checkpoints affect HSPC and their progeny.
B. Uncover the effects of myeloid-specific IC targeting on APC activities. We will examine how myeloid-specific
IC ablation affects the function of key pathways of innate immunity, including STING and NLRP3, and determine
implications on T cell anti-tumor responses.
C. Identify the role of ICs in trained immunity and epigenetic memory. We will identify epigenetic changes in
HSPC and their progeny, and will search for epigenetic marks associated with response or resistance to cancer
immunotherapy. We will perform CRISPR screens to identify novel mediators of long-lasting anti-tumor
protection by myeloid cells. Ultimately, we will use Next-Generation humanized NSG (huNSG) mice to create an
autologous PDX system for personalized immunotherapy based on patient-specific myeloid vulnerabilities.
My vision is to, one day, translate these discoveries into standard care therapies for cancer patients.

Public health relevance
I pioneered many aspects of checkpoint immunobiology and cancer immunotherapy. Here, I outline my vision of unifying and synthesizing our previous work into new approaches for identifying vulnerabilities of innate immunity mediated by immune checkpoints. This knowledge will lead to the identification of new targets for personalized immunotherapy and new strategies to overcome barriers of immunotherapy that could be beneficial in lethal cancers affecting hundreds of thousands of Americans.